A Medical-Grade Smart-Phone Based Monitoring System (Supplement)

Project Summary As the average age of the US population increases and chronic conditions are becoming more prevalent, there is a need to improve the effectiveness of disease prevention, to improve access to healthcare, and to sustain healthy independent living. At the same time, there is an increased availability of new technologies and an ever-improving health information technology infrastructure with >90% of American adults owning a cell phone and 55% having a Smart-Phone. Evolution of these wireless devices is expected to mark a new era in medicine and a transition from population-level health care to individualized medicine, that promises to improve patient-provider communication, adherence to treatment and self-management of chronic diseases in under-served populations. At the same time, despite the availability of a multitude of evidence-based therapies for the treatment of heart failure (HF), a chronic disease, the burden of HF on the US population remains unacceptably high, with an estimated 1 million admissions per year, the majority of which involve the elderly. Moreover, HF readmission rates, are a marker of worse prognosis and represent a significant healthcare expenditure and performance measure for payers, while efforts to reduce the burden of re-hospitalization using conventional markers have been largely ineffective. Therefore, new, low-cost, easy-to-deploy technologies are needed to meet the clinical need for long- term (>1-2 days) monitoring of the ambulatory patients, especially those that do not have easy access to Hospital-based health-care. The central goal of this Emergency Supplement is to investigate the hypothesis that one may develop methods for estimating the beat-to-beat blood pressure variability and to develop a Smartphone app that provides medical grade 12 lead ECG signals, and estimates the blood pressure, SpO2, respiration rate, tidal volume, minute ventilation, level of ischemia and arrhythmia susceptibility, using the on- board computing power of a Smart-Phone, without the need of additional hardware. To achieve the aims of this proposal we will (i) develop and validate a method for estimating the beat- to-beat blood pressure variability; (ii) develop a Smartphone app that provides medical grade 12 lead ECG signals, and estimates the blood pressure, SpO2, respiration rate, tidal volume, minute ventilation, level of ischemia and arrhythmia susceptibility. Success of this proposal will help develop a novel patient-based diagnostic device, that will improve ambulatory patient monitoring (especially those that live in under-served areas), without the need of specialized hardware.

Public health relevance
Project Narrative As the average age of the US population increases and chronic conditions are becoming more prevalent, there is a need to improve the effectiveness of disease prevention, to improve access to healthcare, and to sustain healthy independent living. At the same time, there is an increased availability of new technologies and an ever-improving health information technology infrastructure with 55% of American adults owning a Smart- Phone. The central goal of this application is to investigate the hypothesis that one may develop methods for estimating the beat-to-beat blood pressure variability and to develop a Smartphone app that provides medical grade 12 lead ECG signals, and estimates the blood pressure, SpO2, respiration rate, tidal volume, minute ventilation, level of ischemia and arrhythmia susceptibility, using the on-board computing power of a Smart- Phone, without the need of additional hardware.